Investigating PROTAC-mediated antigen degradation as a novel strategy to enhance cytotoxic T-cell responses against cancer in vivo.

Abstract
Cytotoxic T lymphocytes (CTLs) are key immune effectors and able to kill cancer cells upon recognition of antigens
presented on major histocompatibility complex (MHC) class I molecules. Proteasomal degradation of endogenous proteins
into peptides is essential for this process and a rate‐limiting step in MHC class I presentation. Cancer cells often
downregulate MHC class I presentation to avoid recognition and destruction by CTLs. Despite of significant progress in
cancer immunotherapy, there is currently no therapeutic strategy available to specifically enhance the MHC class I
presentation of cancer‐associated antigens. This, however, could be game‐changing by complementing current therapies
including checkpoint blockade and therapeutic cancer vaccines that remain ineffective in a majority of cancer patient.
This project proposes a novel type of immunotherapy utilizing proteolysis targeting chimeras (PROTACs) to increase
the immunological visibility of cancer towards CTL‐mediated killing by specifically boosting MHC class I presentation.
PROTACs are hetero‐bispecific molecules that link a specific E3 ligase complex with a target protein that is consequently
degraded by the ubiquitin/proteasome system. So far, PROTACs have exclusively been envisioned as chemotherapies to
degrade essential tumor proteins (direct anti‐cancer effect). Interestingly, first clinical trials show the efficacy of custom‐
designed PROTACs targeting endogenous proteins, thereby opening the door to a myriad of novel clinical applications.
Previous studies demonstrate that PROTAC‐mediated degradation of model antigens significantly enhances their MHC
class I presentation. This project explores PROTACs as novel tools to improve CTL‐mediated cancer cell depletion in vivo,
using preclinical mouse models for melanoma. As PROTACs targeting clinically‐relevant cancer antigens are yet to be
developed, it utilizes the recently introduced degradation tag (dTAG) system to degrade proteins expressed in linear fusion
with the degradation tag FKBP12 (F12). Two novel clones of murine B16F10 melanoma cells have already been generated
for these experiments: B16F10 cells expressing a) an F12‐tagged model antigen, and b) a clinically‐relevant melanoma
antigen that has been endogenously tagged with the degradation tag F12 using CRISPR/Cas9‐mediated genome editing.
T‐cell receptor transgenic CTLs specific for these antigens will be used to study PROTAC‐mediated effects on cancer growth
and regression in mice.
Specific aims are (1) to demonstrate that PROTACs can improve cancer‐specific CTL responses and thereby promote tumor
regression in vivo, (2) to show that the PROTAC‐mediated increase in MHC class I presentation can complement existing
cancer immunotherapies, such as immune checkpoint blockade, and (3) to translate these findings into the human system
by providing evidence that PROTACs can enhance the killing of human melanoma cells by patient‐derived CTLs in vitro.
This project will impact the field of cancer immunotherapy by providing first in vivo evidence that PROTACs can be used
as novel tools to enhance MHC class I‐mediated CTL responses in cancer. It therefore extends previous discoveries in the
PROTAC field towards new directions and applications and provides the rationale to design PROTACs directly targeting
endogenous cancer antigens, permitting the clinical translation of this novel approach.

Public health relevance
Project narrative Immunotherapies that reprogram the patient´s immune system to destroy inoperable tumors have revolutionized cancer treatment, but still remain ineffective for a large group of patients due to evasion strategies by cancer cells that escape the radar of immunity. While current approaches aim to enhance the number and activity of cancer‐specific immune cells, no currently available therapeutic strategy specifically re‐exposes cancer cells to the immune system´s radar, which would be critical to improve the success rate of current cancer treatments. In this project, the researchers will develop a novel, complementary immunotherapy that addresses this unmet medical need by increasing the visibility of cancer cells towards immune‐mediated killing with bispecific molecules called PROTACs.